Administrative Core

PROJECT SUMMARY
The overall goals of the administrative core, headed by Principal Investigator Dr. James Gern, are to provide
leadership and the organizational backbone for the program project entitled “Interactions Between the
Microbiome, Immunity, Allergy and Respiratory Health in Traditional Agrarian and Suburban Children “. The
objectives of the core include promoting interaction and collaboration between the Projects and Cores,
maintaining close communication between investigators in Wisconsin sites (LaFarge, Madison, Marshfield),
Chicago and San Francisco, coordinating its interaction with external entities (e.g., Scientific Advisory Board,
NIAID Program Staff, other AADCRC research centers) and providing optimal management of fiscal and other
program resources. By achieving these objectives, the Administrative Core will optimize use of scientific and
fiscal resources and facilitate scientific interaction and discovery.

Public health relevance
PROJECT NARRATIVE Not Applicable to Research Projects under this RFA.